Novel Biologics Designed to Mobilize HIV-specific CTL for Sustained HIV Remission

This application is highly responsive to the major goal of the RFA (AI-18-017) to support the development of
next-generation biologics with immune-modulating effects that may lead to long-lasting HIV remission.
Functional cure of HIV infection has been stymied by the inability of the immune system of HIV-infected
individuals to eliminate effectively latently infected cells following reactivation, resulting in the recurrence of
viremia after stopping antiretroviral therapy. We propose to exploit our increasing understanding of the precise
signals and molecules that mobilize potent T cell responses and sophisticated protein design and engineering
principles to construct novel immunostimulatory biologics consisting of highly stable dimeric IgG Fc-fusion
proteins, termed synTacs. These biologics mimic APC functions by MHC-mediated presentation of defined
peptides to TCRs with delivery of costimulatory and/or cytokine signals. The key element of the synTac
architecture is the use of a single chain MHC molecule, covalently linked to a defined HIV-derived peptide as a
targeting module that triggers the primary TCR activation signal. In parallel, the synTac delivers covalently
linked costimulatory ligands or cytokines to the targeted HIV-specific CD8+ T cells to provide a costimulatory
signal to activate fully the T cells or a cytokine signal to drive T cell proliferation and/or differentiation. We have
validated this approach by constructing synTacs which target the HLA-A*0201-restricted HIV Gag epitope,
SL9, linked to the costimulatory -CD28 or 4-1BBL molecules that specifically activated and expanded primary
SL9-specific CD8+ T cells from HIV-infected individuals. We propose to develop HIV-specific synTacs and
identify the optimal costimulatory and/or cytokine signals to enable them to function as targeted biologics
capable of stimulating, expanding and differentiating selectively patient-derived HIV-specific CD8+ T cells with
the most potent capacity to eliminate HIV-infected T cells. We will determine the in vivo capacity of synTac
biologics to activate, expand and differentiate HIV-specific CD8+ T cells capable of preventing recurrent
viremia by eliminating reactivated latently infected cells using a novel humanized mouse model we have
developed. As an alternative approach, we also propose to harness the potential potency of HIV-specific CAR-
T cells, which recognize antigen with recombinant immunoreceptors such as scFv rather than MHC-restricted
TCRs, by developing an alternative biologic, synTac-like molecules that bind to the CAR-T immunoreceptor to
deliver the optimal costimulatory and/or cytokine signals to amplify HIV-specific CAR-T cell in vivo function.

Public health relevance
Latent HIV-infected cells persist despite years of effective suppressive antiretroviral therapy and reintroduce systemic infection after the cessation of treatment, preventing the functional cure of HIV-infected individuals. The anti-HIV-1 immune response in most patients is inadequate to effectively eliminate reactivated cells, necessitating the development of immunostimulatory modalities to enable HIV-infected individuals to clear the reservoir after reactivation. To accomplish this, we propose to develop a novel class of precision-delivered immunomodulatory biologics to focally stimulate and expand HIV-specific CD8+ T cells in vivo to eliminate reactivated latent HIV-infected CD4+ T cells and evaluate them with novel ex vivo and in vivo models utilizing primary latent HIV-infected CD4+ T cells and CD8+ T cells isolated from virally suppressed HIV-infected individuals.